Cell-Type Specific Mechanisms of Mitral Valve Prolapse

Project Summary
The heart consists of a broad spectrum of cardiac cell types that form distinct cardiac structures critical for
maintaining heart function. These cell populations include not only cardiomyocytes, cardiac fibroblasts,
epicardial cells, endothelial/endocardial cells and smooth muscle cells, but also more specialized cell types
comprising the cardiac valves, cardiac conduction system, etc. Thus, maintaining the function and
homeostasis of these cell types is crucial for optimal heart performance, and disrupting their overall
maintenance can result in distinct heart diseases including mitral valve prolapse (MVP), one of the most
frequent valvular heart diseases (VHD) that has a 2-3% prevalence in the general population. However,
despite recent genetic studies identifying potential genetic loci associated with MVP, what are the specific cell
lineages affected during MVP and how do gene regulatory networks (GRNs) control genetic programs that
direct their pathologic outcomes are key biomedical questions that remain to be elucidated. Thus, to examine
specific cell-types participating in VHDs, particularly MVP, we propose to implement joint single cell/nuclear
(sc/sn) RNA-seq and ATAC-seq technologies (i.e. single cell multi-omics) on
normal and MVP/diseased human
mitral valves. In addition to identifying distinct CV cell-types and their related transcriptional profiles and
chromatin landscape, we seek to elucidate the interactions between cell-type specific cis-regulatory
elements/CREs (e.g. enhancer-promoter connections), which mediate the GRNs that control how CREs direct
gene expression of these cell types in normal and MVP mitral valves. Furthermore, because structural form is
critical for maintaining cardiac valve function, we propose to further investigate the spatial organization of
identified cell types in the mitral valves of human hearts with and without MVP. Through these multi-
disciplinary integrative efforts and analyses, we plan to examine the hypothesis that CREs and their enhancer-
promoter interactions dynamically function and coordinate in a cell-type specific manner to direct lineage-
specific gene expression during mitral valve homeostasis and MVP defects/disease, and altering these highly-
regulated cell-type specific CREs and GRNs, especially in cardiac valve specific cell types, can lead to MVP
and possibly other VHDs. Specifically, we propose to 1) identify human cardiac valvular cell-types and their
gene regulatory programs in normal and MVP defective/diseased mitral valves; 2) investigate the spatial
organization of the diverse cardiovascular cell types of normal and MVP defective/diseased mitral valves; and
3) examine how perturbations of cell-type specific CREs and GRNs during MVP impact cell function and gene
expression.

Public health relevance
Project Narrative The following proposal seeks to illuminate the underlying cell-type specific molecular mechanisms regulating the pathogenesis of mitral valve prolapse. Results from these studies will identify the affected cell-types during mitral valve prolapse, reveal the molecular mechanisms directing their pathologic outcomes and provide insight into developing precise cardiac diagnostics and therapies that are tailored to affected cell-types, thus optimizing therapeutic efficacy for treating mitral valve prolapse and disease.